Structural Circuits Core

PROJECT SUMMARY: Structural Circuits Core
Modern tissue clearing and imaging methods provide the potential for a wealth of information regarding nervous
system anatomy and function. However, to best utilize such methods, understanding the options for tissue
clearing, and the advantages and disadvantages of various imaging methods need to be appreciated.
Furthermore, data handling, analysis, and storage all provide significant obstacles when attempting to make full
use of the capabilities of these modern techniques.
The Structural Circuits Core (SCC) helps researchers best utilize ultramodern technology for the anatomical
mapping of brain circuitry involved in drug addiction. In order to do so, the SCC partners with the University
Imaging Center (UIC), the University Research Informatics - Informatics and Computing (RI-InC) group, the
Minnesota Supercomputing Institute (SCI) and the Data Repository for the University of Minnesota (DRUM). The
SCC provides the infrastructure for automated use of brain clearing technology paired with meso- and micro-
scale imaging of the central nervous system. Importantly, the SCC helps tailor experiments to best utilize the
most appropriate methodological and technological approaches, and, integrating with the Addiction Connectome
Core, provides standardized resources for the analysis, storage, and distribution of these imaging datasets. The
SCC not only allows investigators to quickly and thoroughly interrogate their own data, but also allows
quantitative comparisons across laboratories through a common format structure and custom designed software.